A New Approach to Vision Therapy Based on Naturalistic 3-D Computer Gaming

Summary/Abstract Introduction: iCare will provide eﬀective, home-based vision therapy through a motivating action-based video game that inspires adherence in patients as young as 4 years old. The proposed Phase IIB eﬀort supports development of the commercial system; cloud-based tools for providers and patients; establishment of eﬃcacy and safety; and federal regulatory approval. Problem to be addressed: Convergence insuﬃciency and amblyopia aﬀect millions of children in the U.S. These disorders are associated with symptoms including headaches, blurred vision, eyestrain, diﬃculty concen- trating, and more. They can aﬀect a child's school and social performance and have a detrimental impact on learning. It is known that vision therapy (prescribed neuromuscular and neurosensory exercises) can facilitate restoration of visual function. However, home-based interventions have historically been ineﬀective due to low adherence rates. Long-Term Goal: Improved outcomes and access to care for children diagnosed with convergence insuﬃciency and amblyopia. Phase II Results: In a successful Phase II program, a prototype vision therapy game was employed in a study involving children diagnosed with convergence insuﬃciency (n=19) and amblyopia (n=5). A statistically- signiﬁcant improvement in vision was found in children who used iCare over 12 weeks of therapy. Adherence and technology acceptance results demonstrated improvement over a conventional computer-based intervention. Phase IIB Program Summary: The proposed Phase IIB eﬀort yields a commercial iCare system supporting vision therapy for children as young as 4 years old. New development includes: game enhancements to incor- porate Phase II lessons learned; cloud services integration; a provider-facing web application for monitoring and guiding therapy; a patient-facing web application for software download and parental support; and a HIPAA- compliant data store. Pursuit of federal regulatory approval for the new device will include documentation of safety; creation of users guide and other labeling; and completion of actions supporting premarket notiﬁcation. A network of 10 vision therapy providers around the U.S. will participate in multi-site trials to demonstrate eﬃcacy for treatment of both convergence insuﬃciency and amblyopia. Commercial Opportunity: There are approximately 4.7 million children in the U.S. ages with vision conditions that are treatable by iCare. Tremendous enthusiasm for the iCare product is demonstrated by included letters of support included from 10 diﬀerent vision therapy providers.

Public health relevance
Project Narrative Convergence insuﬃciency and non-strabismic amblyopia are two common binocular vision disorders for which vision therapy is known to be a successful treatment. The downside of commercially-available home-based vision therapy systems is that the recommended eye exercises are highly repetitive, monotonous, and uninteresting, which leads to high levels of patient noncompliance. As with many types of therapy, consistent performance and proper technique are key to achieving therapeutic beneﬁt. The goal of this proposed Phase IIB eﬀort is to make home-based vision therapy a more eﬀective complement to oﬃce-based therapy by incorporating the eye exercises into a fun, interesting, and interactive action video game, which should lead to better compliance and improved therapeutic outcomes.